Targeting the Undruggable in Castration-Resistant Prostate Cancer with FTDR-Stapled Peptide Probes

1 This proposal aims at solving the unmet biomedical needs in the treatment of castrate-resistant
2 prostate cancer (CRPC) which essentially develops to be drug-resistant with ligand-independent
3 androgen receptor (AR) signaling. CRPC cells constantly upregulate c-Myc which was believed
4 to drive the CRPC malignancy and progression. The c-Myc mediated transcription in CRPC also
5 promoted the expression of AR splice variants (AR-V) that were truncated and lacked ligand
6 binding domains thereby endowing CRPC cells resistance to common AR antagonist such as
7 enzalutamide. Thus, c-Myc appears to be an important target for elucidating the AR signaling in
8 CRPC and for novel therapeutic development. Yet, there is a lack of intracellular tools or chemical
9 probes available to effectively target c-Myc, as it belongs to a typical basic helix-loop-helix (HLH)
10 transcription factor family which consist of flat, hydrophilic, and extended surface areas with
11 limited small molecule binding pockets and is considered “undruggable”. Although there have
12 already been c-Myc bound peptide fragments that can effectively inhibit c-Myc-Max dimerization
13 in vitro, most peptides discovered to date suffer from limited biostability and membrane
14 permeability, thereby largely limiting their applications towards in vitro only. We recently invented
15 fluorine-thiol displacement reaction (FTDR) and applied this to staple a diverse set of peptide
16 mimetics, which later displayed significantly enhanced cellular and nuclear uptake. Based on this
17 observation, we hypothesize that application of the FTDR stapling strategy to rationally designed
18 and c-Myc targeted peptide mimetics will result in a class of chemical probes with efficient cellular
19 and nuclear uptake and will efficaciously inhibit c-Myc mediated transcriptional activity in CRPC
20 cells and in vivo mouse xenografts. The first aim seeks to utilize FTDR to staple a H1 peptide
21 sequence designed to target the helix-loop-helix region of c-Myc and will thoroughly evaluate its
22 inhibition of c-Myc-Max heterodimerization and the suppression of c-Myc-mediated transcription
23 in CRPC cells, as well as the associated AR signaling particularly related to AR-FL and AR-V7.
24 The lead hit peptide mimetic that potently blocked the proliferation of CRPC cells, but not regular
25 prostate tissue cells will be eventually assessed in mouse CRPC xenograft models. The second
26 aim will exploit targeting at the C-tail leucine zipper (LZ) domain of c-Myc to directly block the
27 MYC-Max dimerization and will also explore the tandem stapling on the peptide mimetics for both
28 H1 and LZ domains. Completion of these research goals will result in a toolbox of c-Myc targeted
29 cellular probes, which will systematically dissect c-Myc mediated drug resistance and will facilitate
30 future therapeutic development for CRPC treatment or as adjuvants of AR antagonist.

Public health relevance
Project Narrative This proposed project aims to develop novel chemical probes for intracellular targeting of c-Myc, a known oncogenic transcriptional factor but has been long regarded “undruggable”. The inventions here will lead to a systematic understanding of c-Myc-mediated castration resistance and drug resistance in the progression of castrate-resistant prostate cancer (CRPC), using interdisciplinary strategies in organic chemistry, biochemistry and cell biology. This study will provide invaluable insights into c-Myc’s role in the signaling of androgen receptor (AR) including the ligand-independent AR-V7 in CRPC cells, thereby shedding a light on novel treatment approaches of CRPC, e.g., AR- and c-Myc directed.